Comprehensive Training in Oral and Craniofacial Sciences

ABSTRACT
The Comprehesive Training in Oral and Craniofacial Sciences (CTOC) program is an integral
component of graduate and professional training in the Ohio State University College of Dentistry.
This proposal integrates successful, ongoing training programs within the Ohio State University Health
Sciences Center, under the auspices of the College of Dentistry, to address the need for the well-
trained basic and clinical research faculty in oral health and craniofacial research. This proposal
incorporates multiple graduate programs within the College of Dentistry and Health Sciences Center
to create an integrated interdisciplinary research training program. Training opportunities include: 1)
pre-doctoral training in the Oral Biology Ph.D. program in Dentistry and two interdisiciplinary graduate
programs in Biomedical Science Graduate Program in the College of Medicine and the Neuroscience
Studies Graduate Program; 2) dual degree training for the DDS/PhD degrees (DSTP); 3) postdoctoral
training, including post PhD and clinician/scientist programs. The goal of each program is to develop
an extensive research experience that attracts and retains highly qualified trainees for future careers
in academic research in the oral health and craniofacial sciences. Over the past 10 years, 49
trainees entered the program (this number includes the DDS/PhD, PhD and postdoctoral fellow
appointments). In the dual degree program, 18 entered, 12 finished, 4 are currently in training, 1
transfer out to another college and 1 did not finish. In the PhD graduate programs, 17 candidates
entered, 11 graduated, 4 are currently in training, and 2 did not finish. In the postdoctoral training
program, 14 trainees entered the program, 11 completed training, and 3 are currently in training. A
total of 19 different faculty members mentored the 49 trainees. In summary, this training program
offers an innovative interdisciplinary science curriculum based on the mechanisms of human disease,
and an extensive and flexible curriculum in oral sciences, coupled with the long-term mentorship of
experienced interdisciplinary faculty, to produce highly trained scientists and clinician scientists for
careers in academic research.

Public health relevance
Narrative The Comprehensive Training in Oral and Craniofacial Sciences (CTOC) is an established program designed to train the next generation of basic and clinical research faculty in oral and craniofacial research. The program uses a flexible graduate curriculum and established interdisciplinary research programs to provide high quality training and career development. Training is set in a highly interactive health sciences center that has support from the College of Dentistry, OSU Graduate School, OSU Center for Clinical and Translation Science (OSU CCTS) and the NIDCR. The OSU CCTS is funded by a multi-year Clinical and Translational Science Award (CTSA) from the National Institutes of Health, and provides financial, organizational, and educational support to the CTOC.